Modified Use of E-cigarettes and Marketing on YouTube

PROJECT SUMMARY I was awarded my first R01 (parent grant) on June 1, 2020. However, the university-wide hiring freeze due to the COVID-19 pandemic and the birth of my child and maternity leave set back the project progress. Thus, this Administrative Supplement, which is focused on supporting first-time grantees who experienced critical life events, will be used to catch up on the delayed progress from Year 1 of the parent grant. Please note that the Specific Aims of this Supplement remain the same as those of the parent grant. The overall goal of the parent grant is to understand ways in which youth modify e-cigarettes, their motivations for doing so, and marketing sources, using YouTube analysis, survey methodology, and expert evaluation. We will identify modified uses of e-cigarettes and marketing using fictitious youth YouTube viewer profiles to search for e-cigarettes using a browser plug-in and custom scripted web-crawling and then machine learning to automatically code the videos to identify e-cigarette modifications and marketing source. Our Advisory Committee (AC) of subject matter experts in tobacco regulatory science, social media, youth tobacco use, toxicology, communications, and tobacco marketing will apply their knowledge to assess the potential impact of these identified modified uses on appeal, addiction, and health effects of e-cigarettes to identify those which are amenable to FDA regulations and communications. We will then conduct an in-depth analysis of these selected behaviors using a combination of machine learning and detailed human coding on youth-accessible YouTube videos to understand: 1) components that are modified (e.g., batteries, cartridges/pods, e-liquids), 2) motivations for modification (e.g., enhance user experience, reduce perceived harm), 3) marketing sources (e.g., online shops, pro-e-cigarette organizations), and 4) appeal (number of likes, views). We will also use an online survey with adolescent and young adult e-cigarette users (N=1000) to examine the prevalence, appeal, motivations, risk perceptions, and marketing exposure related to these modified uses and their predictors (i.e., demographic variables, past-month e-cigarette use frequency, e-cigarette dependence, other tobacco/substance use, interpersonal and intrapersonal risk factors). The results of this study will provide the FDA with novel evidence to 1) develop regulations to prohibit the manufacturing and marketing of e-cigarette components that can be modified by youth, 2) restrict youth-accessible marketing of e-cigarettes on social media such as YouTube, and 3) develop prevention campaigns to educate youth about the harms of modifying e-cigarettes.

Public health relevance
PROJECT NARRATIVE PUBLIC HEALTH RELEVANCE: E-cigarette use among youth is high; thus, to inform youth e-cigarette prevention, we will examine the youth appeal of the product, such as the ability to modify or “hack” the devices and their related components for unintended uses and marketing on popular social media, YouTube. We will use mixed-methods (i.e., machine learning, survey methodology, expert evaluation) to achieve our aim. The results of this study will provide the FDA with novel evidence to develop regulations to prohibit the manufacturing and marketing of e-cigarette components that can be modified, restrict youth-accessible marketing of e-cigarettes on YouTube, and develop prevention campaigns to educate youth about the harms of engaging in these behaviors.